Center for Health, Work and Environment

The purpose of the Center for Health, Work & Environment (CHWE) Center of Excellence in Total Worker Health
(TWH) is to advance the overall safety, health, and well-being of workers in Federal Health Region 8 and the
nation, through transdisciplinary research, effective interventions, outreach and communications,
education/training, and rigorous evaluation that inform improvements in all of the above. CHWE addresses the
need for research on Total Worker Health intervention strategies, focusing on the large number of workers and
workplaces at highest risk of occupational fatality, injury, and illness. Specifically, CHWE research will build on
the team’s experience in creating innovative TWH interventions and practical outreach tools for small
businesses, the education industry, and other high-risk sectors such as agriculture. These groups employ a large
number of contingent, seasonal, underemployed, low wage, minority, and rural workers. There is an opportunity
to address serious gaps in transdisciplinary research that is needed to impact the well-being of these populations.
In addition, CHWE will apply and test both existing and new theoretical frameworks to improve generalizability
and efficacy of Total Worker Health interventions and dissemination strategies. CHWE has six goals:
1. Provide leadership and expertise in research and practice to integrate the protection from work-related safety
and health hazards with the promotion of injury and illness prevention efforts to advance worker well-being.
(Leadership/Expertise)
2. Extend the research evidence base regarding the integration of protection and promotion of worker-related
safety, health, and well-being. (Research)
3. Increase awareness, adoption, and implementation of Total Worker Health best practices, programs, and
policies across the region through communication and dissemination, education, and implementation that is
evidence-based, accessible, feasible, effective, and culturally appropriate. (Practice/Outreach)
4. Advance the adoption of policies that improve work-related safety, health, and well-being at local, state, and
federal levels. (Policy)
5. Build Total Worker Health workforce capacity in public and private sectors, in academia, and in practice
through education and strategic partnerships. (Capacity)
6. Improve Center impact through a rigorous evaluation program. (Evaluation)
Through our Research and Outreach Cores, CHWE will work across sectors, with a particular focus on the
agricultural sector, the service sector (education), and small businesses across all sectors. Each Core and
project reflects our commitment to addressing the Healthy People 2030 goals related to OSH, which are primarily
addressed through the National Occupational Research Agenda (NORA). In particular, the NORA Healthy Work
Design and Well-Being (HWD) cross-sector is relevant to our TWH Center of Excellence goals and objectives.

Public health relevance
The Center for Health, Work & Environment will have high public health impact by meeting Region 8 and national needs for healthy and safe worksites and workers through its program of research, r2p, education/training, partnerships and other dissemination activities. It will advance scientific knowledge by establishing new, innovative worksite programs to benefit both workers and employers, test relevant theoretical models, and emphasize helping those working in small enterprises, and in other high-risk industries, including education and agriculture, among other sectors with high need.